Center for Innovative NeuroTech Advancement - CINTA

Project Abstract - Overall
We propose to create the Center for Innovative NeuroTech Advancement (CINTA), a new
center for rapid transformation of emerging technologies into commercially viable,
clinically focused solutions for disorders of the nervous system. The PD/PIs, Drs. Steven
Schachter and Paolo Bonato, together have many decades of experience creating and
managing complex multi-institutions, multi-disciplinary, national translational research
organizations, and expertise in neurotechnology-related research, and will leverage their
experience to further innovate, adapt, and deploy the well-developed, proven approach to
needs-driven healthcare technology innovation pioneered, developed, and validated for 23
years by the Consortia for Improving Medicine with Innovation & Technology (CIMIT). Led for
the past 23 years by Dr. Schachter and colleagues, CIMIT has a proven track record of success
as a national center for healthcare innovation and a unique model to identify unmet medical
needs; find, fund, and facilitate technology-based projects to solve those needs; and rapidly
move these innovations from concept to manufacturing to commercialization to the end-user.
Combining their decades-long expertise and interest in neurological disorders and rehabilitation,
the PD/PIs will oversee the advancement of projects under CINTA’s five cores: Administrative
Core, Outreach Core, Evaluation Core, Innovator Subprojects Core, and Resource Subawards
Core. Paul Tessier, Program Director for the Administrative Core, will have overall responsibility
for integrating the activities of the different cores to accomplish the overall goals of the proposed
Center under the guidance of the Center PD/PIs. The Administrative Core will ensure ongoing
input from NIH program directors and science officers, as well as input from the Steering
Committee members who are integral in providing guidance to the program to help diversify the
types of projects as well as increase representation of proposers of varying backgrounds. Key
center activities to accomplish the overall goals include established needs assessment and
project solicitation processes, and CIMIT’s virtual collaboration platform, CoLab, to help CINTA
investigators and facilitators track important deliverables in four areas critical to commercial
success. CoLab will also be used as a platform for shared CINTA resources, such as a CINTA
website with access to resources available to key stakeholders. Finally, CINTA will draw upon
the well-established national and international collaboration networks of CIMIT and Spaulding to
achieve CINTA’s goals and enhance externally funded collaborations.

Public health relevance
Project Narrative The goal of the Center for Innovative NeuroTech Advancement (CINTA) is to rapidly transform emerging technologies into commercially viable, clinically focused solutions for disorders of the nervous system as a hub under the NIH Blueprint MedTech: Incubator Hubs program. CINTA will support the advancement of neurotechnology solutions by adapting and improving upon the proven model that CIMIT developed and implemented for RADx Tech to accelerate promising neurotechnologies that address critical areas of unmet needs in the diagnosis and treatment of nervous system disorders to human-grade prototypes. CINTA plans to find, fund, facilitate, and accelerate 15 projects per year through this program.